Admin-Core-001

The Michigan Prostate SPORE Administration Core is responsible for the leadership, guidance and
management of this proposal. The Administration Core oversees all aspects and performs numerous duties
across the wide scope of the SPORE to support the translational goals of the investigators. The SPORE
Administration Core is guided by the following Specific Aims: Specific Aim 1: Provide scientific, programmatic
and administrative leadership to all aspects of the SPORE. Specific Aim 2: Develop, facilitate and monitor
progress of translational aims with project Co-Leaders. Specific Aim 3: Identify, support, and facilitate scientific
collaborations. The Administration Core is charged with creating a culture of collaboration through fostering
and helping to establish and maintain successful collaborations. Specific Aim 4: Facilitate communication
between investigators and groups within the Michigan Prostate SPORE as well as with other institutional
SPOREs, the SPORE network outside the University of Michigan (U-M), Karmanos Cancer Institute (KCI), NCI
and investigators across the spectrum of translational cancer research. Specific Aim 5: Perform fiscal and data
management functions. Specific Aim 6: Coordinate patient advocacy and provide functional and ethical
oversight to projects and cores. The Core provides support and oversight to ensure that all investigators have
IRB and animal approvals in place to conduct research. The Core will develop and maintain an advocacy portal
for our prostate cancer patient community. Arul M. Chinnaiyan, MD, PhD (U-M) serves as Core Director.
Ganesh Palapattu, MD (U-M) and Elisabeth Heath, MD (KCI) will serve as Core Co-Directors of the
Administrative Core and provide overall scientific oversight. Dr. Chinnaiyan will be responsible for overall
program organization and fiscal oversight as well as the Biostatistics/Bioinformatics and
Biospecimen/Pathology Cores. Dr. Palapattu will be responsible for mentorship and development of
collaborators and trainees, oversight of the Career Enhancement Program and synergies between U-M and
KCI programs. Dr. Heath will oversee clinical trials and therapeutics, patient advocacy, minority community
engagement, and the Developmental Research Program. Ms. Jill Miller has served as the Michigan Prostate
SPORE administrator since 1998 and will continue in this role. This Core provides the framework to support
the success and mission of the Michigan Prostate SPORE as a cohesive group of investigators committed to
supporting translational research in prostate cancer.

Public health relevance
The Administration Core is responsible for the leadership, guidance and management of the Michigan Prostate SPORE. In fulfilling these responsibilities, the Administration Core provides the framework to support the success and mission of the Michigan Prostate SPORE as a cohesive group of investigators committed to supporting translational research in prostate cancer.